Montana Pediatric Clinical Trials Site

PROJECT SUMMARY
During the first four years of the ECHO IDeA States Pediatric Clinical Trials Network (ECHO ISPCTN), the
Montana Pediatric Clinical Trials Site (MPCTS) has been successful in building the necessary infrastructure,
team, and partnerships to participate effectively in multi-center clinical trials. The newly formed infrastructure
includes clinical and research offices, dedicated exam and consultation rooms for participants, database and
computer facilities and clinical research expertise from several centers through the University of Montana. The
research team is comprised of a pediatric clinician/scientist as principal investigator, two research nurses, an
epidemiologist and a recently added second pediatrician. Each team member has gained experience through
multiple professional development opportunities, which have included ECHO ISPCTN Data Coordinating and
Operations Center-offered didactic presentations, manuscript writing team membership and leadership, clinical
trial protocol development leadership, and most importantly the invaluable growth that occurs with participation
in three ECHO ISPCTN clinical studies. The team is now well positioned to gain further from a robust clinical
research skills development plan designed by a new Senior Faculty Development Leader, who has extensive
expertise in both clinical trials and mentorship. We are ready to participate in the next phase of ongoing ECHO
ISPCTN trials as well as clinical trials in development. To facilitate continued and successful pediatric clinical
trial participation, we have established relationships with the major pediatric inpatient facilities in the state,
including their healthcare providers and research institutions, as well as with outpatient pediatric practice
groups and care providers throughout western Montana, including the Family Practice Medicine Residency and
Partnership Health Center, a Federally Qualified Health Center. We have also gained support from a newly
formed innovative rural outreach organization, Ahana, a telemedicine collaborative for afterhours care in rural
communities. Our established and active engagement with two IDeA program-supported Clinical and
Translational Research Centers in Montana has and will continue to serve as valuable resources in
professional development, research design and biostatistics, and community and stakeholder engagement, the
last of which is critical as we extend our ECHO ISPCTN activities into more rural areas of the state. The ECHO
ISPCTN has provided a pathway for including sites in clinical trial research that have not historically done so.
As we look toward the future, the overall goal is to build on the ECHO ISPCTN’s and MPCTS’s successes and
leverage existing infrastructure to expand the reach of ECHO ISPCTN clinical trials into rural and underserved
areas in Montana. More inclusive and generalizable pediatric clinical trials will improve both the quality of
clinical trial research and the health of children across the ECHO ISPCTN.

Public health relevance
PROJECT NARRATIVE The Montana Pediatric Clinical Trials Site (MPCTS) at the University of Montana has been an effective member of the ECHO IDeA States Pediatric Clinical Trials Network (ISPCTN). Prior to MPCTS, few pediatric clinical trials and even fewer in ECHO priority areas had been conducted in the state of Montana. As we look toward the future, our objective is now to build on these successes and expand the reach of ECHO ISPCTN clinical trials into rural and underserved areas in Montana.